Total Synthesis of Alstilobanine A Using a Strained Cyclic Allene

Project Summary/Abstract
Increasingly, medicinal chemists are moving away from “flat” sp2-rich molecules for exploring bioactivity
in recognition that the most selective compounds often contain a high degree of sp3 stereogenicity, therefore
lending them three-dimensionality to match their biological targets. Additionally, stereochemically well-defined
drugs frequently have fewer off-target effects owing to their high affinities for their intended targets, which can
ultimately have a positive impact on human health. Therefore, synthetic methods that allow for the rapid
construction of sp3-rich structures are of significant value to the drug discovery and manufacturing process.
Recently, the use of strained organic intermediates to assemble stereochemically-dense products has garnered
much attention. Highly strained reactive organic intermediates such as benzynes and other arynes, which were
once thought to be purely theoretical, are now routinely used in conventional synthesis owing to their many uses,
yet reactions with these intermediates generally give rise to planar products. However, a much less utilized
strained intermediate is the strained cyclic allene (SCA) which has great potential in the construction of sp3-rich
compounds. The proposed research aims to develop methodology that will allow 6-membered cyclic allenes,
generated under mild conditions, to engage in highly regio- and stereoselective Diels-Alder cycloadditions with
2-pyrones and related 2-pyridones. The resulting products will be highly-functionalized, sp3-rich (hetero)cyclic
structures that should prove as useful synthetic building blocks for the construction of complex molecules.
Toward this goal, this methodology will be employed as the key step in a total synthesis of the indole alkaloid
Alstilobanine A. This effort will result in the first asymmetric synthesis of this target and also the first use of SCAs
in the total synthesis of a natural product.

Public health relevance
Project Narrative Natural products often serve as starting points for the development of new medicines to treat human disease; thus, pursuing their synthesis is of vital importance to supply material for biological and medicinal chemistry studies and to inspire new synthetic methodologies. The aim of this proposed research is to complete a concise total synthesis of the vasorelaxant indole alkaloid Alstilobanine A using new methodology for strain- promoted Diels-Alder reactions between cyclic allenes and 2-pyrones. The results of these studies should prompt the further use of unconventional strained intermediates for the preparation of other biologically interesting complex molecules.